Building and InnovatinG: Digital heAlth Technology and Analytics (BIGDATA)

PROJECT SUMMARY: Overall
The BIGDATA CCCR encompasses three distinct and synergistic cores – the Methodologic and Health
Informatics Core, a newly proposed Dissemination, Implementation and Community Engagement (DICE)
Resource core, and an Administrative Core. All three are aligned around the theme of patient-centered research
using real-world evidence, mobile and digital health (e.g. apps, virtual reality), informatics, and advanced
analytics. The DICE Core will facilitate our important subtheme of health equity and community engagement. In
this renewal application, we will continue to foster our goal to bring innovative tools and methods to the research
community to effectively advance the NIAMS mission for rheumatic and musculoskeletal disease (RMD)
research. We will support innovative approaches, methods and technologies necessary to transform healthcare
in the 21st century through achieving these Specific Aims:
Specific Aim 1: To harness the outstanding, innovative, and synergistic RMD research expertise at UAB to
expedite clinical, translational, and informatics-related science through the utilization of our Methodologic and
Health Informatics (MHI) Core. The MHI core is composed of a diverse team with expertise in biostatistics,
informatics (e.g., natural language processing, machine learning, artificial intelligence, data visualization),
epidemiology, and implementation science.
Specific Aim 2: To foster health equity and community engagement through our newly proposed Dissemination
and Implementation and Community Engagement (DICE) Resource core. DICE will focus on three main
capacities: 1) study recruitment and engagement, particularly of individuals historically under-represented in
research; 2) Dissemination and implementation (D&I) research, translating research into practice in academic
and community settings; and 3) fostering the patient voice in all aspects of clinical research, starting with the
study question, extending to representing patients’ input in the data acquisition process to ensure that data
collected is relevant to patients, and bridging to implementation so that that patient views are well represented.
Engagement with the DICE Core will be facilitated in part by our Patient Advisory Committee and through
tested structures to engage patients in pre- and post-award roles.
Specific Aim 3: To comprehensively coordinate our CCCR’s activities, effectively leverage institutional
resources (e.g. the UAB CCTS) and promote training for both early and established investigators in state-of-
the-art methods applicable to the NIAMS mission through diverse enrichment activities, all overseen by our
Admin Core.

Public health relevance
PROJECT NARATIVE The UAB Building and InnovatinG: Digital heAlth Technology and Analytics (BIGDATA) Core Center for Clinical Research (CCCR) encompasses three distinct and synergistic cores (Administrative, Methodologic and Health Informatics [MHI], and the Dissemination, Implementation and Community Engagement [DICE] Resource Core) aligned around the theme of big data and real-world evidence that spans the continuum of research. BIGDATA harnesses informatics, digital health tools, and advanced analytics in pursuit of its theme and sub- theme of health equity and community engagement. The goal of the BIGDATA CCCR is to bring the innovative research and technology tools necessary to transform healthcare in the 21st century and to improve outcomes for patients with rheumatologic and musculoskeletal diseases.